UC Santa Cruz PREP

Abstract - This is a renewal of our successful 2019-2023 PREP program. UC Santa Cruz PREP is in its 8th year
and has supported 50 scholars (43 completed training and 6 currently supported). Of our seven cohorts of PREP
scholars that completed training, 3 enrolled in master’s programs, and 32 of 43 (74.4%) have been admitted to
top-ranked biomedical Ph.D. programs throughout the country. Of the 32 accepted into Ph. D.s programs, 34%
have completed their Ph.D. training, 16% have received their Master’s, and are currently in leadership positions
in academia and industry. 50% are at different stages of their doctorate studies. Two honorable mentions and
five scholars received prestigious NSF graduate fellowships. Ten additional scholars received coveted graduate
fellowships at their universities. 19 co-authored peer-reviewed publications were produced by PREP scholars
based on their research at UCSC. The current cohort of 6 scholars has just received numerous graduate school
invitations, and we are optimistic that they will be accepted into Biomedical Ph.D. programs. Of our 50 scholars
(30 female/20 male), 86% were first-generation college students, 8 were African American, 34 were Hispanic, 3
were Southeast Asian, and 3 were Native American. In this renewal application, we plan to maintain the same
class size, admitting yearly cohorts of 6 post-baccalaureate scholars from underserved and underrepresented
minority populations. Based on our extensive involvement with this program, we continue to modify and improve
the PREP experience for our scholars. Specifically, we propose to increase our state and national recruiting
efforts. In addition, we will foster collaborations, retreats, and seminars with the three other Bay Area PREP
programs. While great strides have been made over the past 20 years toward increasing the participation of
historically marginalized groups in science programs at the undergraduate level, similar increases have not been
realized at the doctoral level. The UC Santa Cruz PREP program is well suited to meet this urgent national need
to expand diversity and increase participation of historically marginalized students in Biomedical Ph.D. programs.
The outstanding research environment at UC Santa Cruz will provide PREP scholars with state-of-the-art
resources and faculty who are leaders in their disciplines. Our scholars will also benefit from UCSC’s experience
and outstanding success, i.e., training underrepresented and historically marginalized students. PREP faculty
and staff will collaborate with campus diversity partners, the Division of Graduate Studies, the Division of Physical
and Biological Sciences, the Jack Baskin School of Engineering, and the Office of the Chancellor to ensure the
success of the program by creating a welcoming environment for all members of the UCSC PREP community.
PREP scholars will participate in intensive mentoring and professional development programs that enhance their
ability to gain admission to highly competitive doctoral programs. By training new professionals in cutting-edge
research, the UCSC PREP program will help advance the NIH mission of equity and excellence and enhance
our workforce with diverse leaders in scientific and technological discovery leaders.

Public health relevance
Narrative The biomedical research community at UC Santa Cruz has played a leading role in broadening participation in pre-graduate and graduate research training programs. Through extensive programming and various support services based on best practices, we create an inclusive and equitable environment for underrepresented students to succeed in attaining higher degrees in the biomedical field. With this PREP proposal, we will broaden training opportunities for recent graduates so that they will be able to gain admission to and complete a top-ranked Ph.D. program.